Detecting Epigenetic Signatures to Prevent Avoidable Racial Inequities in TNBC (DESPARIT)

Project Summary/Abstract
Breast cancer is the most common cancer and second leading cause of cancer mortality for women overall.
Black women experience 40% higher breast cancer mortality rates than White women despite similar
incidence rates. More than half of this racial disparity is attributable to triple negative breast cancer (TNBC),
an aggressive subtype of invasive breast cancer that is twice as prevalent among Black vs. White women.
TNBC is also more common among young women, often presenting before screening mammography is first
recommended There is therefore a critical need to identify young women at risk for TNBC for earlier referral
to screening and other prevention interventions. Several TNBC risk factors have been identified (e.g., limited
breastfeeding, obesity, alcohol use), which are more prevalent in Black relative to White women and help to
explain racial disparities in TNBC incidence. However, prior attempts to develop risk prediction models
based on these risk factors have not succeeded. Thus, novel approaches for the identification of young
women at risk for TNBC are necessary to close racial disparities in breast cancer mortality. Promising new
evidence suggests that epigenetic biomarkers can overcome the limitations of traditional risk factor
approaches and be used to personalize breast cancer prevention. Epigenetic-mediated changes in
inflammatory processes as a result exposure to TNBC risk factors may contribute to TNBC pathogenesis.
The identification of an epigenetic-based susceptibility/risk biomarker could be utilized in primary care
settings to inform the recommendation to initiate screening mammography earlier and target modifiable risk
factors among women at elevated risk for TNBC. To capitalize on this opportunity, the overall objective of
this proposal is to develop the infrastructure to conduct this type of biomedical research in Delaware, an
IDeA state that leads the US in both TNBC and alcohol-attributable breast cancer. We aim to develop a new
prospective cohort to conduct comprehensive assessments of exposures for established and emerging
TNBC risk factors in tandem with epigenetic immune patterns from a representative sample of breast cancer
patients. We hypothesize that the cumulative exposure to reproductive, metabolic, alcohol, and
environmental risk factors induces a distinct epigenetic immune signature. The long-term impact of this
research includes reducing the burden of breast cancer for all women and closing racial disparities in breast
cancer mortality.

Public health relevance
Project Narrative Even though the number of new breast cancer cases are similar for Black and White women, Black women die from breast cancer at a 40% higher rate. About half of this disparity can be explained by the higher rates of triple negative breast cancer (TNBC) observed among Black women, an aggressive subtype of breast cancer that often presents before mammography is first recommended. This project aims to develop the research capacity to identify of a biomarker of risk for TNBC, which can help to prioritize women for earlier screening and other prevention programs, and ultimately close racial disparities in breast cancer.